A novel behavioral intervention to promote adherence in heart failure

Heart failure (HF) affects nearly 6 million Americans and leads to significant impairments in functioning,
quality of life, and survival. Health behaviors (e.g., physical activity, low-sodium diet, medications) are
associated with improved health, including survival, in HF, but most HF patients do not adhere adequately to
these behaviors. Existing health behavior programs have had limited impact on adherence and cardiac
outcomes, are inaccessible to many patients, and do not target psychological factors independently associated
with heart health. Motivational interviewing- (MI-) based programs have been shown to increase engagement
in HF self-care behaviors but may not be sufficient to improve downstream health outcomes in HF patients.
Positive psychology (PP), which utilizes systematic activities (e.g., using strengths, expressing
gratitude) to cultivate well-being, may be an important component of a health behavior program in HF. Positive
psychological constructs are prospectively and independently associated with both health behavior adherence
and improved cardiovascular health, and PP interventions have been shown to improve these constructs and
increase health behavior adherence in patients with or at risk for cardiovascular disease. Furthermore, PP
could be combined with MI to promote self-efficacy, motivation, and intention to engage in health behaviors.
We recently completed a multi-stage project (REACH for Health) to develop a 12-week, telephone-
delivered, combined positive psychology-motivational interviewing (PP-MI) intervention to promote physical
activity, diet, and medication adherence in HF. We now aim to examine the efficacy of this program, with
additional twice weekly PP and health behavior text messages for a total of 24 weeks, compared to an MI-
based educational control condition, in an NIH Stage II, randomized clinical trial in 280 patients with New York
Heart Association class I-III HF and suboptimal adherence to physical activity, diet, or medications. The
primary study outcome will be change in objectively measured health behavior adherence (composite outcome
of moderate to vigorous physical activity [measured via accelerometer], sodium intake [24h urinary sodium],
and medication adherence [Medication Event Monitoring System electronic pill bottle]), and we hypothesize
that PP-MI will lead to greater improvements in adherence compared to the MI-based educational condition.
We also will measure the intervention’s impact on psychological health, quality of life, functional outcomes,
markers of cardiovascular health (e.g., body mass index, lipids, glucose), and major adverse cardiac events.
We will utilize our team’s expertise in clinical trials, cardiology, and PP- and MI-based interventions to
effectively and efficiently perform the proposed trial, which—consistent with the goals of PA-18-722—aims to
“test [an] innovative approach…for maintaining individuals’…adherence to complex health care regimens.” If
effective, we will examine the intervention’s effects on cardiovascular health outcomes in a larger trial and will
begin to explore ways to implement this potentially highly scalable intervention in clinical settings.

Public health relevance
Project Narrative Most patients with heart failure struggle to adhere to behaviors important for heart health, and existing interventions to encourage these health behaviors have had limited impact and do not focus on psychological factors associated with adherence. In the proposed trial, we aim to determine whether a 12-week, telephone- delivered, behavioral intervention that involves performing simple activities to enhance well-being and setting goals for healthy behaviors—with additional text message support for 24 weeks—helps patients with heart failure take medications, maintain a healthy diet, and be more physically active. If the intervention is successful at improving adherence, we will plan a larger trial to determine whether the intervention reduces hospitalizations and improves survival in this group of high-risk patients.